Aging in Puerto Rico: Longitudinal Follow-Up of the PREHCO Study

Please see Research Plan, as per PA-20-166 instructions. ?? the Research Strategy section should be completed and must include a summary or abstract of the funded parent award or project ?.?

Public health relevance
PROJECT NARRATIVE The purpose of this supplement is to provide research and career development training opportunities for Cheyanne Barba, an underrepresented minority graduate student at UAB. The individualized development plan proposed for Ms. Barba includes research mentoring, participating in staff trainings and team meetings, training in statistics, and conducting her own research with the Puerto Rican Elderly: Health Conditions (PREHCO) study. Her research will focus on the association between cognitive function and outcomes of everyday function and mortality in this sample of older Hispanic adults.